The impact of social evaluation on perception of facial affect in adults with social anxiety

Project Summary/Abstract
Social anxiety disorders are one of the most common and widely impairing mental health issues among adults
in the United States. Social anxiety is characterized by anxiety from anticipation of aversive future social
events. Elevations in such anticipatory anxiety may bias perception of threat stimuli through enhanced
connections between the amygdala and visual sensory regions. Upon viewing threatening face stimuli, people
with social anxiety display increased activity in perceptual and face-processing regions and increased
connectivity between these regions and the amygdala, suggesting a possible etiological account for social
anxiety disorders. However, current research examining the underlying neural origins of biased perception and
its contributions to anxiety disorders suffers from important limitations. First, much of this work has focused on
how attentional mechanisms increase vigilance to threat stimuli, and less is known about sensory
representations of threat in visual circuitry. Second, the degree to which extant models of perceptual biases in
anxiety are generalizable beyond white, middle SES adults is not known. Finally, most fMRI studies that
investigate biases in emotion perception in social anxiety disorder have employed univariate analyses which
do not characterize how information is represented in neural activity patterns, limiting inferences about how
social anxiety might influence sensory representations of threat. In two aims, the proposed study will address
these limitations by applying univariate, multivariate, and functional connectivity analyses, in an ethnically
diverse sample of young adults with and without social anxiety. Aim 1 will test whether trait social anxiety
influences neural and behavioral sensitivity to threat upon viewing ambiguous faces blended between
threatening (fear/anger) and safe (happy) expressions. Aim 2 will test whether experimentally inducing
anticipatory anxiety via a social threat influences neural and behavioral threat sensitivity. Signal detection
theoretic metrics will measure behavioral threat sensitivity, or the degree of threat affect required for a face to
be judged as fearful or angry. Univariate and multivariate measures of neural activity will characterize neural
threat sensitivity in perceptual (V1, fusiform gyrus) and emotional (amygdala, anterior insular cortex, dorsal
anterior cingulate cortex, dorsomedial prefrontal cortex, ventrolateral prefrontal cortex) brain regions.
Functional connectivity analyses will probe the cortical networks underlying anticipatory anxiety in social
anxiety. By inducing anticipatory anxiety, I can test whether social threat increases connectivity between the
amygdala and perceptual regions and concomitantly alters multivoxel sensory representations of ambiguous
facial affect, which has not yet been done. Together, these aims focus on an understudied but central feature
of social anxiety disorders, builds on my knowledge of new multivariate analytic techniques and promises to
provide new information about the neural mechanisms underlying social anxiety.

Public health relevance
Project Narrative Social anxiety may bias sensory perception of threat stimuli through enhanced connections between threat neurocircuitry and sensory regions. However, research on the underlying neural origins of biased perception and its contributions to social anxiety disorders suffers from important limitations including homogeneous demographic samples (i.e., predominantly White upper-middle class treatment seeking youth) and insensitive analytic methods. This project uses experimental manipulation and computational neuroimaging to probe the neural mechanisms underlying the association between social anxiety and biases in emotion perception in an ethnically diverse sample of young adults.